Parvalbumin interneurons regulate nucleus accumbens synapses and behavior

PROJECT SUMMARY
Substance use disorders (SUDs) remain a medical and societal burden with a relative paucity of prevention and
treatment options. The nucleus accumbens (NAc) is an essential hub integrating cognitive, contextual, sensory
and affective information into behavioral outcomes. Changes in excitatory (glutamatergic) synaptic function in
the NAc is a leading molecular mechanism by which illicit drug exposure leads to the behavioral manifestations
represented by SUDs. However, a gap in the input specificity, temporal dynamic, mechanism(s) and
consequences of plasticity and drug-induced plasticity onto parvalbumin expressing fast spiking interneurons
(PV-FSIs) remains. The long-term goal is to understand the mechanisms by which NAc circuits mediate
reinforced behaviors. The overall objective of this application is: (1) to define input-specific plasticity mechanisms
controlling excitatory synaptic strength onto PV-FSIs, (2) to elucidate mechanistic contributions of these
synapses to reinforcement behavior, and (3) to determine contribution of NAc PV-FSI AMPA receptors to
cocaine-evoked plasticity of MSN excitatory synapses. The central hypothesis is that functionally-distinct
corticolimbic and thalamic synapses onto PV-FSIs in the NAc support cocaine-evoked adaptations in
reinforcement behavior and circuit function. Aim 1 is designed to determine mechanisms of stimulus and
cocaine-evoked synaptic plasticity of specific excitatory inputs onto NAc PV-FSIs. Aim 2 will determine the role
of glutamatergic signaling onto NAc PV-FSIs in modulating reinforcement behavior in an input specific manner.
And, Aim 3 will elucidate the contribution of NAc PV-FSI AMPA receptors to cocaine-induced plasticity of MSNs.
The rationale for the proposed studies is that they will provide a detailed understanding of the functional
organization of NAc PV-FSI microcircuitry, revealing synaptic mechanisms by which PV-FSIs adapt to stimuli
and support reinforcement behavior as well as influence cocaine-evoked reorganization of output circuits. To
accomplish these aims a combination of whole-cell patch clamp electrophysiology, Drugs Acutely Restricted by
Tethering (DART) pharmacology, optogenetics, reinforcement behavior and transgenic mice will be used. The
proposed research is innovative because it represents a new and substantive departure from the status quo by
shifting focus to the modulation of PV-FSI feedforward inhibition as a master regulator of NAc function and thus
reward-related behavior. Completion of the work in this proposal will: (1) establish plasticity mechanisms at
specific excitatory inputs onto PV-FSIs. (2) Establish a causal relationship between NAc PV-FSI AMPA receptors
and reinforcement behavior and (3) demonstrate that NAc PV-FSI AMPA receptors are necessary for cocaine-
evoked plasticity of MSN excitatory synapses. Completion of this work is expected to have a positive translational
impact by examining an understudied but integral component of the reward system and will provide a launching
point for the development of novel strategies to prevent and treat Substance Use Disorders.

Public health relevance
PROJECT NARRATIVE The nucleus accumbens is an essential hub in the reward system integrating cognitive, contextual, sensory and affective information into behavioral outcomes. The proposed work will test the hypothesis that feed forward microcircuits within the nucleus accumbens regulate reinforcement behavior and are hijacked by drugs of abuse. By defining circuits and synaptic mechanisms necessary for reward processing, the proposed research is relevant to the NIH and NIDA's mission that pertains to developing fundamental knowledge that will help reduce the burdens of addiction.